The Effect of Interval Exercise on Functional Outcomes in Veterans with COPD and OSA

The term "Overlap Syndrome" (OS) is used to describe the presence of both chronic obstructive pulmonary
disease (COPD) and obstructive sleep apnea (OSA) in a single patient. Due to premature aging, patients with OS
are prone to developing functional decline up to 20 years earlier than the general population. The International
Classification of Functioning, Disability and Health (ICF) evaluates functional status in chronic pulmonary disease
globally in 5 domains. We propose to study validated outcomes in 3 of these domains: 1) participation in life
situations, measured by the 36-item Short Form Survey (SF-36); 2) physical activity (PA), measured by daily step
counts; and 3) cardiovascular health, measured by cardiorespiratory fitness (CRF), flow-mediated endothelial
dilation (FMD) and serum hs-CRP, lipids and glucose. Our long-term goal is to develop an exercise strategy
tailored to Veterans with OS which will reduce their risk of functional decline through increased PA.
Excessive daytime sleepiness (EDS) is a common symptom of OSA that persists in a third of patients
despite optimal treatment with continuous positive airway pressure (CPAP). EDS is associated with decreased
quality of life and daily activity and increased risk of CVD and further, improves with exercise. Understanding the
relationship of EDS with these domains of functional status within the context of an exercise intervention provides
an opportunity to tailor exercise strategies to this complex patient population. We propose to investigate Veterans
with EDS-OS because they are at highest risk for functional decline yet have the greatest barriers to exercise.
Exercise trials performed in patients with COPD or OSA show that moderate intensity continuous training
(MICT) decreased EDS and increased SF-36, PA, CRF and hs-CRP. MICT remains underutilized despite its
well-established benefits. Thus, we propose to test moderate intensity interval training (MIIT), a novel 5-minute
interval-based exercise intervention that meets the individual needs and capacities of Veterans with OS. In
addition, we will study behavioral barriers to exercise using the self-efficacy for exercise (SEE) Scale and
Brainwriting Premortem, an efficient stakeholder feedback technique, to facilitate the design of a future home-
based MIIT intervention and its successful translation into bouts of daily PA (future Merit Application).
We propose a randomized trial of MIIT (5-minute intervals at 50% VO2peak 3 times weekly for 12 weeks)
in Veterans with OS vs. standard of care controls. The Epworth Sleepiness Scale (ESS) will be assessed at
baseline. Veterans with the EDS-OS phenotype (ESS >10) will enter the MIIT trial. The specific aims are:
1) To determine the effect of MIIT on participation in life situations compared to usual care control
Hypothesis 1: MIIT improves: a) SF-36 physical and mental scores; and b) Epworth Sleepiness Scale.
Hypothesis 2. The EDS-OS phenotype will be associated with poor SF-36 scores and will exhibit improvement
with MIIT that is mediated by improved Epworth Sleepiness Scale.
2) To determine the effect of MIIT on physical activity compared to usual care control
Hypothesis 3: MIIT increases daily step count as measured by accelerometry.
Hypothesis 4. The EDS-OS phenotype will be associated with greater limitations in baseline step count and will
exhibit improvement with MIIT that is mediated by improved Epworth Sleepiness Scale.
3) To determine the effect of MIIT on cardiovascular health compared to usual care control
Hypothesis 5: MIIT a) increases CRF (VO2peak) and FMD; and b) decreases serum hs-CRP, lipids and glucose
Hypothesis 6: The EDS-OS phenotype will be associated with greater limitations in baseline cardiovascular
health and will exhibit improvement with MIIT that is mediated by improved Epworth Sleepiness Scale.
4) To explore behavioral barriers to translation of MIIT into sustainable healthy lifestyle change
Hypothesis 7: Low self-efficacy for exercise is associated with poor compliance to MIIT.
Hypothesis 8: Brainwriting Premortem will identify pre-implementation barriers to a future home-based MIIT.

Public health relevance
The term "Overlap Syndrome" (OS) is used to describe the presence of both chronic obstructive pulmonary disease (COPD) and obstructive sleep apnea (OSA) in a single patient. Veterans with OS who also have excessive daytime sleepiness (EDS) are at highest risk for functional decline yet have the greatest barriers to exercise training. Thus, there is a critical need to identify novel exercise strategies that meet the individual needs and capacities of Veterans with EDS-OS. We propose to test moderate intensity interval training (MIIT), a novel exercise intervention whose translation into durable lifestyle change may be facilitated by the feasibility of short bouts of increased PA. Our proposal addresses key knowledge gaps in rehabilitation research by investigating the clinical phenotype of EDS-OS to determine the association with functional outcomes and response to a novel exercise intervention with the goal to reduce functional decline. Results will inform a larger exercise trial and Merit application that will facilitate my career goal to be an independent scientist in exercise rehabilitation in OS.